Core--Information Technology

The present core will centralize the information technology and computer needs for the BCHH Center of Excellence. Specifically, this core will develop databases, websites, and other technologically-based methods for entering and storing data, and make it available as appropriate to other Center and Network members, as well as other investigators and health care providers in the research and clinical community. In broad terms, this core will facilitate both the internal infrastructure we are developing within Columbia University/NY-Presbyterian Hospital, and the public infrastructure we are developing that will be available to the mind-body/behavioral medicine community of researchers and clinicians.